Role of chemokines in neuronal function and survival

Abstract: HIV-associated neurocognitive disorder (HAND) persists in spite of effective control of HIV
replication by modern antiretroviral therapies. Adjunctive therapies treating HAND in virally suppressed
patients are needed. Studies over the previous funding period suggest that cognitive impairment in HAND is
correlated to decreased dendritic spine density in prefrontal cortex (PFC) neurons, which is influenced by
several factors such as HIV proteins, chronic inflammation, and opioid use. Importantly, this process may be
reversible. Our previous work revealed that activation of the CXCL12/CXCR4 chemokine axis increases
dendritic spine density in medial PFC neurons likely leading to cognitive improvement. On the other hand,
studies in multiple species - including humans - demonstrate that opioids compromise this pathway,
representing a potential mechanism of accelerated HAND. With the long-term goal of introducing targeted
therapeutics for HAND, this study will dissect the mechanisms whereby the CXCL12/CXCR4 axis regulates
spatiotemporal expression of discrete dendritic spines in PFC neurons. Additionally, the proposed studies will
determine the relationship of the spine changes with cognitive function and how opioids or HIV impact these
structural and functional outcomes. Experiments will focus on the Rac1/PAK pathway, a main regulator of
spine stabilization coupled to the CXCR4 receptor. We hypothesize that CXCL12/CXCR4 signaling enhances
working memory and cognitive flexibility by stabilizing normally transient thin spines. Conversely, impairment of
CXCR4/Rac1/PAK contributes to synaptic and cognitive deficiencies associated with HIV infection and opioid
exposure. Studies in Aim 1 will dissect the signaling pathways downstream of CXCR4 that regulate dendritic
spines in cortical neurons, and characterize the effect of CXCL12 on spine dynamics. The proposed
experiments will establish the importance of the Rac1/PAK pathway in CXCL12-induced spine regulation and
cognitive performance. Aim 2 will examine the effects of morphine on spine morphology and function, in the
presence and absence of CXCL12. Although CXCL12 may work to enhance stability of dendritic spines, the
development of a transient spine to one that is integrated into the neuronal circuitry is dependent on additional
factors, including neuronal activity and protein synthesis. Since morphine and other µ-opioid drugs affect
neuronal activity in various ways, these compounds may have additional effects on spines that are unrelated to
CXCR4 inhibition. Finally, Aim 3 will define alterations of synaptodendritic architecture and Rac1/PAK
pathway activity after in vivo exposure to HIV proteins and morphine, using a small animal model of HAND.
These studies will also determine whether CXCL12 treatment rescues synaptic deficits and cognitive
performance in a PFC-mediated behavioral task highly relevant to HAND. Behavioral studies will be linked
with downstream spine and protein/gene expression analysis in the same group of animals to establish the
causal link between changes in cognitive ability and altered synaptic density or connectivity.

Public health relevance
Narrative Although combination antiretroviral therapy (cART) has indisputably produced great benefits to the health and well being of HIV-infected patients, HIV-associated neurocognitive disorders (HAND) are still un-treatable and are becoming more common as the HIV+ population on cART ages. In pursuit of a novel approach for HAND therapy, our group has identified a chemokine protein that reverses damage of neuronal micro-architecture caused by neurotoxic HIV proteins, and may revert cognitive impairment. Expanding on these promising studies, we are proposing to determine the mechanisms by which neuronal architecture is restored by the chemokine, which is expected to produce new drug targets for HAND, and will provide novel insights into the neurobiology of learning and memory that will likely translate to other neurological disorders.